ADMINISTRATIVE CORE

The purpose of Core A, Administration is to (1) provide administrative and biostatistics support for the Program Director and all of the project and core investigators, and to (2) promote tight coordination, organization and integration of the four Projects and the two scientific cores to maximize productivity and leverage the interdisciplinary synergies of the program. The Administrative Core will be responsible for: 1) All fiscal matters, including: Preparation of monthly statements and annual budgets for the Program Director and each Project and Core Leader;Coordination of all purchase orders for equipment and service contracts;Tracking the proportionate effort of all individuals in projects and cores to assure compliance with the budget. 2.) Arrangement and scheduling of monthly meetings of the Steering Committee to discuss the program's progress, both with respect to scientific as well as operational issues. The steering committee will consist of the Pi's of each project and co-Pi's of each core along. 3.) Scheduling of bi-weekly research in progress seminar series. 4.) Quality control oversight of all communications derived from Program Project activities, including manuscripts, abstracts, oral or poster presentations at scientific and medical symposia, and press releases to translate the findings for the lay community. 5.) Compliance with all institutional and federal processes, including the tracking and oversight of all Human Subject and Animal Research Protocol submissions, and compliance with OSHA, Radiation Safety, and HIPAA regulations. 6.) Communication to all program Pi's and Co-Pi's via e-mail, phone and meetings all information pertinent to the program such as electronic pdf files of newly published manuscripts or summaries of presentations at regional or national meeting that relate to the program. 7.) Provide clerical support for all matters related to the program. 8.) Provide biostatistics support for planning and interpreting mouse and human studies;9.) Arrange the Internal and External Advisory Board meetings to review the program. 10.) Arrange the invitation and visits for outside speakers for the program.